A Mixed Methods Exploration of Prenatal Polysubstance Use

PROJECT SUMMARY/ABSTRACT
Substance use during pregnancy can lead to negative maternal and infant outcomes. Polysubstance use in
pregnancy is particularly salient considering that the increase in number of substances used carries the
compounded risk for both the mother and fetus of each individual substance, as well as potential negative
interactions between substances. Prenatal polysubstance use in the U.S. is increasing, and understanding of
the behavioral patterns of such use is critical. Current research supports the relationship between prenatal
individual substance use and biopsychosocial factors. However, there is limited research examining
relationships between social determinants of health (SDoH) and prenatal polysubstance use. This information
is important given that exposure to adverse SDoH factors can increase the level of stress experienced by
individuals, which subsequently increases risk for experiencing substance use issues, posing an equity issue
for such vulnerable populations. The overall objective of this research will be to better understand prenatal
polysubstance use in the U.S. by approaching the characterization in two ways (qualitative and quantitative)
through a socioecological lens, and triangulating findings. Specifically, this project will: 1) conduct qualitative
interviews among pregnant or postpartum people engaging in prenatal polysubstance use to understand the
biopsychosocial context of such behaviors, and 2) utilize an existing national pregnancy survey (CDC PRAMS)
to quantitatively establish psychosocial outcomes of polysubstance use behaviors among pregnant people,
which will be the first to incorporate SDoH into such a model. First, 20 qualitative interviews will be conducted
with pregnant or postpartum people engaging in polysubstance use to understand the experiences and
environment that surrounds such use. Second, the findings of these interviews will inform an exploration of
present-day patterns of pregnant polysubstance use using CDC PRAMS data. These patterns will be
characterized using latent class analysis (LCA) to define unique groups of polysubstance use, with the five
SDoH health domains as external validators: economic stability, education access and quality, healthcare
access and quality, neighborhood and built environment, and social and community context. The strength of
this approach lies in the specificity of quantitative analyses, while being complemented by the depth of lived
experiences. This research will be the first to our knowledge to determine the relationship quantitatively and
qualitatively between SDoH and prenatal polysubstance use in the U.S. This dissertation project will lay the
foundation for future work to determine factors we may be able to target for prevention, treatment, and
initiatives to decrease the burden of prenatal polysubstance use.

Public health relevance
PROJECT NARRATIVE While the prevalence and severity of individual substance use during pregnancy is well-documented, less is known about perinatal polysubstance use. This research will inform prevention efforts by 1) conducting qualitative interviews among pregnant or postpartum people engaging in prenatal polysubstance use to understand the biopsychosocial context of such behaviors, and 2) utilizing an existing national pregnancy survey (CDC PRAMS) to quantitatively establish psychosocial outcomes of polysubstance use behaviors among pregnant people, which will be the first to incorporate SDoH into such a model. This research will inform the understanding of risk for prenatal polysubstance use, highlighting potential biopsychosocial intervention targets and informing clinical efforts to improve healthcare for this unique population.